Cancer Adoptive Cell Therapy (Can-ACT) Network Coordinating Center at Mayo Clinic

PROJECT SUMMARY/ABSTRACT – NETWORK COORDINATING CENTER
The Network Coordinating Center (NCC) will facilitate and be responsible for network-wide coordination and
harmonization of scientific and clinical needs of the funded UG3/UH3 centers comprising the Cancer Adoptive
Cellular Therapeutics (Can-ACT) Network. The Network Coordinating Center at Mayo Clinic (NCC-MC) will
serve as the administrative hub and coordinating center for all network-related trials and projects. This will
include multiple aspects of the functioning of this network, including the administrative and scientific
coordination of the Can-ACT Network. The administrative coordination will include (a) providing leadership and
facilitating interactions across the network, (b) providing administrative infrastructure to support the activities of
the Can-ACT Network, and (c) the coordination of the restricted collaborative funds and administrative
supplements for the network. Scientific coordination of this network will include several different critical
components, including (a) identifying and establishing strategies for facilitating reagent and specimen sharing,
(b) identification and harmonization of process development and manufacturing steps for cell product
management and utilization for the functioning of the network between centers and the ICN Core, (c)
biostatistical support and collaboration for preclinical and clinical research studies and centralized data
management and shared data governance, and (d) bioinformatics and data science support and collaboration.
The infrastructure, expertise, and experience of the individuals at Mayo Clinic with national coordination of
translational and clinical research is extensive, making this group well-positioned to function as an outstanding
coordinating center for the Can-ACT Network. The leadership of this proposed coordinating center brings with
them complementary and deep experience and background across these key aims, and they have worked
extensively with multi-institutional trials, consortia, and networks as well as cooperative groups in research
leadership, trial coordination and implementation, data structures, and importantly development of SOPs and
guidance for newly formed collaborative research networks across multiple institutions. Beyond the experience
and expertise, the NCC-MC also leverages institutional infrastructure and resources to adapt and evolve as the
Can-ACT Network develops and grows through the expected and necessary collaborations across all
UG3/UH3 centers and project leaders.

Public health relevance
PROJECT NARRATIVE – NETWORK COORDINATING CENTER The Network Coordinating Center at Mayo Clinic (NCC-MC) will facilitate and be responsible for network-wide coordination and harmonization of scientific and administrative needs of the funded UG3/UH3 centers as part of the Cancer Adoptive Cellular Therapy (Can-ACT) Network. The NCC-MC will serve as the administrative hub and coordinating center for all network-related trials and projects, including but not limited to: (1) administrative coordination of the Can-ACT Network, (2) oversight and management of biological specimens and associated policies, and (3) provision of analytic and data management support for the Can-ACT Network, including biostatistical and bioinformatics and data science collaboration and clinical and correlative data management. The infrastructure, expertise, and experience of the individuals at Mayo Clinic is extensive for the national coordination of translational and clinical cellular product-based research, making this group well- positioned to effectively function as an outstanding coordinating center for the Can-ACT Network.